Development of a Phenotype-based Predictive Analytic for Acute Myeloid Leukemia

Project Summary
The 5-year overall survival from acute myeloid leukemia (AML) is less than 30%. While some patients are cured
with initial induction therapy, most patients relapse, and the expected outcomes in patients with relapsed and
refractory (R/R) AML are dismal. For this reason, developing methods to identify therapies likely to benefit R/R
AML patients is a top priority. This proposal aims to address critical unmet needs with a unique Academic-
Industry Partnership (AIP) between investigators at Vanderbilt University Medical Center, Karyopharm
Therapeutics, and Notable Labs. The BCL2 inhibitor, venetoclax (VEN), is transforming clinical practice for AML,
but activity in R/R AML is less pronounced, and resistance occurs in most patients. AIP investigators currenty
lead a multi-site investigator-sponsored study, testing VEN in combination with the selective inhibitor of nuclear
export (SINE) selinexor (SEL) in a Phase I trial for R/R AML (NCT03955783). This SEL/VEN trial grew from the
discovery that SEL synergizes with VEN and overcomes resistance mechanisms in some VEN-insensitive
patient samples. Given this, our AIP team has worked together to develop a precision medicine functional
platform for this novel combination in R/R AML. Notable Labs utilizes an automated high-throughput,
immunophenotype-based flow cytometry method to provide real time drug sensitivity data on multiple, specific
cell populations simultaneously within a given patient sample. Building from the only annotated cohort of patient
samples treated with SEL/VEN in the world, we propose to develop a precision medicine functional assay to
identify R/R AML patients most likely to benefit from SINE/VEN combination therapy. We will build, refine and
optimize the functional platform for SEL/VEN with samples from our current Phase I study and train the platform
on samples from the Phase 2 SEL/VEN clinical trial proposed by the AIP. Aim 1 will focus on determining assay
parameters specifically for SEL/VEN in R/R AML. Aim 2 will train the model with the phase II clinical trial of
SEL/VEN in R/R AML, and Aim 3 will contextualize the predictive analytic model on heterogenous genotypes
found in R/R AML. At the conclusion of this study, the functional medicine platform will be a companion
diagnostic ready for external validation which we will lead in a phase III efficacy trial of SEL/VEN in R/ R AML,
and serve as proof-of-principle for development of similar therapy-specifc precision medicine tools.

Public health relevance
Narrative Despite remarkable improvement in responses in de novo AML patients, outcomes in relapsed or refractory AML remain dismal. We bring together a unique academic-industry precision-medicine team of investigators at Vanderbilt University Medical Center, Karyopharm Therapeutics, and Notable Laboratories to develop a predictive analytic tool in the context of developing a promising new combination therapy of the BCL2 inhibitor, venetoclax (VEN), and selinexor (SEL), a selective inhibitor of nuclear export (SINE) compound shown to sensitize patient samples to VEN. We will establish the preliminary efficacy of SEL/VEN in relapsed or refractory AML patients and train a functional assay to predict response and resistance to SEL-VEN therapy.